A Genetic Engineering Toolbox for Marmosets (GETMarm): Development and optimization of genome editing and assisted reproduction techniques for marmoset models

Project Summary
The major goal of this grant proposal is to develop and refine germline genetic manipulation technologies for
marmoset embryos to facilitate the generation of genetic engineered marmoset models for brain research. To
increase the efficiency of generating genetic engineered marmoset models with desired DNA changes, one of
the technologies we proposed to develop in the grant is preimplantation genetic testing (PGT). Briefly, after
CRISPR editing in marmoset embryos, we culture the embryos in vitro and take either one embryonic cell
(from 6-8 cell stage embryos) or 5-10 supporting cells (from 100-200 cell blastocysts). We will amplify the DNA
region by PCR and sequence the DNA fragment to identify embryos with correct editing while the embryos are
still in culture. We need to get the sequencing data withing 24 hours to ensure good embryo survival. Once we
identify the embryos with correct editing, we will then implant the correct embryos to recipient marmosets.
Currently, the fastest commercial sequencing service is 48 hours and even that is not guaranteed. We have
also checked with Broad sequencing platform service and their turnaround time is about two weeks and they
only do large batch sequencing. Fortunately, Thermo-Fisher has recently released a bench-top sequencer that
is easy to use and we could get the sequencing done within hours. This equipment will greatly facilitate our
PGT and dramatically increase our successful rate of genome editing in marmosets.

Public health relevance
Project Narrative To increase the efficiency of generating genetic engineered marmoset models with desired DNA changes, one of the technologies we proposed to develop in the grant is preimplantation genetic testing (PGT). However, we recently realized that to perform PGT effectively, we will need a bench-top sequencer to obtain genotyping data within 24 hours of sampling. This was not in the original budget and we don't have unobligated balance in our year 2 budget. We therefore request a supplement to cover 50% of the cost with the other 50% from a match fund from the Director of the McGovern Institute for Brain Research at MIT.